T Cell and General Immune Responses to Influenza

In this Project 2 entitled

Public health relevance
We seek to understand at multiple levels-molecular, cellular and organismal—how the immune systems of humans in different age groups are constituted and how their T lymphocytes respond or fail to defend against specific influenza strains. It is expected that the assays that will result from these studies will aid in the development of more effective vaccines and an understanding of immunological